Engineering a physiologically-tuned reservoir intravaginal ring releasing lactic acid for the treatment and prevention of bacterial vaginosis

Project Summary
Millions of women in the U.S. suffer from bacterial vaginosis (BV), a vaginal condition initiated by marked
overgrowth of polymicrobial bacterial populations that not only leads to foul-smelling discharge but also greatly
increases the risks to diverse sexually transmitted infections and pre-term birth. Antibiotics can provide
transient relief from initial BV infection, but they do not prevent BV from recurring, with BV recurring as
frequently as twice a month). Nearly half of women treated with antibiotics will experience at least one episode
of BV recurrence within a year. There is no product on the market that can provide sustained protection against
BV. Interestingly, some women are incredibly resistant to BV; they typically have a Lactobacilli crispatus-
dominant vaginal microbiome that results in high levels of both D- and L- lactic acid (LA), which serves as a
potent and broad-spectrum microbicide against numerous sexually transmitted pathogens and BV-associated
polymicrobials. Motivated by this clinical observation, we have been developing an intravaginal ring (IVR) that
can sustain high vaginal levels of LA. However, we face an important question: how much LA release is
needed to do so in humans? Unfortunately, virtually nothing is known about the rate of loss of LA in the vagina.
This lack of knowledge in turn increases the product development risks of advancing an intervention that is
ineffective due to insufficient LA release. Here, we seek to directly address this question by directly measuring
the rate of LA loss from the vagina of both women with healthy, L.crispatus-dominant microbiota and women
with BV-infection, including determining both transepithelial loss and loss via introital discharge (Aim 1). Based
on the findings, we would then engineer LA-IVR with LA release rates that match the human physiology,
enabling us to sustain high levels of LA for over 30 days (Aim 2). Towards this goal, we have now developed a
proprietary reservoir-IVR system that allows us to precisely tune LA release rates with near zero-order release
kinetics, achieving LA release at rates orders of magnitude greater than what had been previously reported.
Successful measurements of the steady-state rates of loss of LA in the human vagina not only will enhance our
understanding of human vaginal physiology, but also ensures we are advancing a LA-IVR that can dose
sufficient amounts of LA to likely make a clinical impact (thus minimizing the risks of advancing an inadequate
product). The simplicity of our LA-IVR design ensures both ease of production and low manufacturing costs of
the eventual product, which in turn should maximize potential public health impact and commercial viability of
the product, both in the U.S. and in other low- and middle-income countries suffering the greatest societal and
economic burden from BV infections.

Public health relevance
Project Narrative Bacterial vaginosis (BV) is a frequently recurring vaginal condition that suppresses protective lactobacillus bacteria and greatly increase risk of sexually transmitted infections and adverse pregnancy outcomes. To meet the urgent need for sustained protection against BV, Mucommune is developing an intravaginal ring that will continuously release high levels of lactic acid (LA) for over 30 days. The LA-IVR can be produced at low cost, and its successful development would establish an affordable and effective method for protecting millions of women from BV in the U.S. and worldwide.